3D High Density Collagen I Improves Modeling of Metastatic Pancreatic Cancer

PROJECT SUMMARY/ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) is an extremely aggressive cancer, where most patients (~80%) are
diagnosed after metastatic spreading has already occurred, coupled with a dismal overall 5-year survival rate of
13%. Novel therapeutic treatments often show promise in preclinical models then fail when advanced to human
clinical trials. This naturally leads one to ask how these preclinical models differ from the clinical disease. PDAC
tumors are characterized by a complex tumor microenvironment (TME). Its dense fibrotic stroma is known to
contain rich amounts of fibrillar type I collagen, known to be a major driver of metastasis and treatment
resistance. Interestingly, most preclinical models used to study the PDAC TME or test promising treatment
modalities rely on the injection of tumor cells mixed in basement membrane extract (BME, e.g. Matrigel®) to
establish primary tumors. However, BME is composed primarily of laminin and collagen IV while containing no
collagen I. Our preliminary results show the importance of incorporating collagen I into PDAC preclinical models.
Injecting PDAC cells with 3D high density type I collagen (HDC) generates tumors with significantly more
collagen content and extensive metastasis, even in PDAC cells lines that do not normally metastasize in mice.
We developed the first successful orthotopic PDAC tumor using 3D HDC in a mouse model, which we utilized to
discover a stark contrast in survival between mice in the HDC group versus the BME group. These findings
together support our hypothesis that PDAC cells grown in 3D HDC recapitulate the metastatic behavior of
human PDAC tumors better than existing models. By accomplishing our aims, we will better understand how the
collagen-rich PDAC TME drives metastasis and resistance and engineer a synthetic alternative to better study
PDAC preclinical models. Leveraging in vitro and in vivo studies through a multidisciplinary approach, the goals
of our proposed project are to (1) demonstrate that HDC co-injection models recapitulate aggressive human
PDAC better than traditional BME models; (2) identify how HDC drives collective invasion and metastasis.
Because natural matrices contribute to experimental variability, we will (3) develop a synthetic hydrogel
substitute comparable to HDC to enable broader implementation in PDAC preclinical research. Our
multidisciplinary team, led by a female surgeon and female engineer, will produce a better method of modeling
PDAC that more accurately recapitulates metastatic progression and therapeutic resistance. Our approach will
provide a more realistic preclinical setting to test new therapeutic strategies and the potential to reveal novel
treatment strategies for PDAC.

Public health relevance
PROJECT NARRATIVE Novel treatments that show promise in preclinical models of pancreatic ductal adenocarcinoma (PDAC) often fail when translated to human clinical trials. PDAC tumors are notoriously dense with large amounts of high density type I collagen (HDC), whereas most preclinical models involve co-injection of cells in basement membrane extract (BME, e.g. Matrigel®), which contain no type I collagen. In this project, we will demonstrate that co- injection of cells in HDC instead of BME recapitulates aggressive human PDAC better than traditional BME models and develop a synthetic hydrogel substitute, comparable to HDC, to enable broader implementation in PDAC preclinical research.